Acetylation Regulates YAP Subcellular Localization and Cardiac Regeneration

PROJECT SUMMARY
Ischemic heart diseases, which include heart failure, are linked to systolic dysfunction resulting from the loss of
cardiomyocytes (CMs). The ultimate therapeutic approach for this condition is the regeneration of new CMs.
Recent studies on heart regeneration suggested that stimulating the natural division of CMs, known as mitosis,
is a promising strategy for myocardium regeneration. YAP is a transcriptional cofactor that shuttles in and out
of the nucleus in response to physiologic inputs. The Hippo pathway is a kinase cascade that suppresses YAP
by phosphorylation, which prevents YAP from entering the nucleus. Our previous studies and others have
shown that inhibition of the Hippo pathway causes YAP nuclear localization, promoting CM proliferation and
suppressing pathologic remodeling in mice and pigs, suggesting that targeting the Hippo pathway could be a
potential therapeutic approach for treating ischemic heart diseases. However, CM proliferation induced by the
inhibition of the Hippo pathway is self-limiting, suggesting other mechanisms can regulate the function of YAP.
In the pathophysiological context after myocardial infarction (MI), we found that YAP is transiently localized to
the nucleus of CMs, which is associated with acetylation. YAP is acetylated by CBP/p300, but YAP
deacetylation is regulated by SIRTs and its cofactor NAD+. Here, we propose that metabolic stresses regulate
YAP acetylation through NAD+, which affects YAP activity and subcellular localization. We will test how the
NAD+/SIRT1/2 axis regulates YAP acetylation in mouse models with myocardial infarction and investigate
whether combined targeting the Hippo pathway and YAP acetylation can enhance cardiac regeneration more
effectively than targeting either pathway alone. This mechanism involves a Hippo-independent, post-
translational regulation of YAP activity called acetylation. Unlike the Hippo pathway-mediated YAP
phosphorylation that occurs in the cytoplasm, we found YAP to be acetylated in the nucleus,
representing an additional mechanism for YAP regulation. This comprehensive understanding of the
mechanism of YAP in regulating cardiac regeneration and remodeling can lead to the development of more
effective therapeutic strategies for treating ischemic heart diseases.

Public health relevance
PROJECT NARRATIVE Heart disease is the top cause of death globally, and the heart's limited capacity to form new cells means that it cannot repair itself after an injury. YAP is a protein that promotes the formation of new cardiomyocytes and improves heart function recovery. This project aims to investigate how YAP activity is regulated in pathophysiological conditions after heart injury to develop better therapeutic strategies for cardiomyocyte renewal and heart repair.